TRANSCRIPTIONAL REGULATION OF ANTIBODY RESPONSES AND IMMUNITY

Abstract: The duration of antibody responses varies widely with the specific vaccine or infection. The specific
features of the immunogen and host responses that are responsible for these differences remain poorly
understood. In this application, we describe two transcription factors of the BTB/POZ family which exert
opposing effects on the duration of antibody production. The first of these factors, Zbtb20, promotes plasma
cell survival and is required for primary long-term antibody responses when aluminum salts, but not Toll-like
receptor ligands are used as the adjuvant. The second factor, Zbtb32, promotes plasma cell death and limits
the duration of antibody production following memory B cell recall responses, but not primary antibody
responses. Based on these findings, we propose to establish the cellular events that explain how adjuvants
influence the duration of immunity, and to uncover the physiological consequences to the diversity of antibody
responses when recall responses persist for too long. Moreover, we propose to identify the molecular
mechanisms of how Zbtb20 and Zbtb32 function to control the duration of humoral immunity.

Public health relevance
Project Narrative: The length of time that antibodies persist after vaccination and infection and the efficacy of these antibodies against related pathogens varies widely. The goal of this proposal is to identify genetic factors and cellular events that control the duration of immunity after vaccination.